Impact of removing low yield penicillin allergy alerts on surgical site infection rates

Project Summary/Abstract
Patients with penicillin allergies receive toxic antibiotics that place them at higher risk for adverse events,
including surgical site infections. However, most patients who report a penicillin allergy can tolerate penicillins
and other beta-lactam style antibiotics without any problems. One large healthcare system silenced low risk
penicillin alerts without increasing adverse events for patients. BJC HealthCare, our 14 hospital network
headquartered in St. Louis, MO, silenced low risk penicillin alerts in 2019 based on these findings. We have
been able to demonstrate that silencing low risk penicillin allergy alerts was also safe in our healthcare system.
For this project, we propose to evaluate the impact silencing low risk penicillin allergy alerts for surgical
patients in our healthcare system. We hypothesize that removal of the alert will be associated with an increase
in cefazolin prescribing for common surgeries via an interrupted time series analysis. We also hypothesize that
the removal of the alert will be associated with a reduction in surgical site infection rates among penicillin
allergic patients but not control (non-penicillin allergic) patients using an interrupted time series analysis.
We believe that this project aligns well with the mission of AHRQ to “produce evidence to make healthcare
safer, higher quality, more accessible, equitable, and affordable, and to work within the U.S. Department of
Health and Human Services and with other partners to make sure that the evidence is understood and used.”
Indeed, this intervention to silence low risk penicillin allergy alerts would be scalable in any healthcare system
without requiring any additional resources. If effective, this simple intervention could be easily added to existing
AHRQ toolkits or provide preliminary data for a large pragmatic prospective multicenter study. This is unique
among most research projects, as implementation of new innovations requires substantial investment among
healthcare systems that often have limited resources.
We are well suited to complete the proposed work. All of the proposed data has already been collected during
routine patient care. We already have IRB approval, and we have collected much of it prior to grant
submission. For the remaining steps, we have assembled an outstanding team of investigators that includes
leaders in infection prevention, antimicrobial stewardship, allergy/immunology, and biostatistics. These
individuals have a strong track record of collaborating, obtaining extramural funding, and completing their
proposed research projects.

Public health relevance
Project Narrative Penicillin allergic patients who receive 2nd line antibiotics for surgical site infection (SSI) prophylaxis are at higher risk of postoperative SSIs. We silenced low risk penicillin allergy alerts in our 14-hospital healthcare system. We propose to measure how much this changed SSI prophylaxis prescribing and SSI rates in our healthcare system.